In-vivo biotinylation to capture neuron-specific proteomic changes in mouse models of Alzheimer's disease pathology

PROJECT ABSTRACT
Alzheimer’s disease (AD) is a devastating and growing epidemic without means of definitive diagnosis,
prevention, or disease-modifying treatment. AD features a decades-long prodromal period in which amyloid-β
(Aβ) accumulation precedes neurodegeneration and cognitive impairment. This time period represents a critical
window of therapeutic intervention to intercept before irreversible neurodegeneration. Synaptic loss is the
strongest pathological correlate to cognitive decline, although neuron specific and microglial dependent
mechanisms contributing to synaptic loss are unknown. To this end, there are critical gaps in our understanding
of (1) early molecular changes occurring in synapses driven by Aβ pathology, (2) the impact of age on Aβ-
induced molecular changes in the synapse, and (3) the role of microglia in these early synaptic changes. The
overall goal of this proposal is to identify age-dependent and synapse-specific effects of Aβ deposition in mouse
models of AD, and to determine the role microglia play in Aβ-driven synaptic proteomic changes. My central
hypothesis is that microglia are key mediators of early synaptic proteomic changes that occur as a result of
progressive Aβ pathology. I will rigorously test my hypothesis through two specific aims. First (Aim 1), I will
characterize early and age-dependent effects of Aβ pathology on protein-level changes in neuronal synapses. I
will study neuronal as well as synapse-specific changes in a mouse model of Aβ pathology (5xFAD) by
expressing a promiscuous biotin ligase (TurboID) to specifically label proteins expressed in neurons followed by
synaptic fractionation. This will allow us to purify neuronal proteins from synapse-fractionated preparations
without requiring cell type isolation. By applying mass spectrometry (MS) to these samples, I will define protein
changes occurring specifically in neurons as a result of Aβ pathology and aging (1.5, 3 and 6 months) using a
combination of differential expression and network approaches (Aim 1). These studies will reveal protein
signatures altered specifically by amyloid pathology which emerge before synaptic loss and cognitive impairment.
Next (Aim 2), I will mechanistically determine how microglia contribute to early Aβ-driven pathological changes
in neurons using an in-vivo microglia depletion strategy (CSF1R inhibition). Neuron-labeled 5xFAD and WT mice
will undergo microglia depletion and we will apply MS to identify early neuronal protein changes that are
microglia-dependent and microglia-independent. By integrating mouse proteomic data from both aims with
existing human brain proteomic generated through the accelerating medicines partnership (AMP-AD), I will be
able to identify molecular changes occurring in neurons in early pre-symptomatic stages of AD progression.
Successful completion of these aims will address critical gaps in the fields of neuroproteomics and AD,
particularly the need to resolve early molecular changes occurring in neurons and synapses as a result of aging,
Aβ pathology and immune mechanisms.

Public health relevance
PROJECT NARRATIVE The early pre-symptomatic phase of Alzheimer’s disease impacts neuronal synapses at the molecular level even before pathological changes are visible. Defining the earliest molecular changes occurring in synapses is necessary to understand disease mechanisms of Alzheimer’s disease and to identify novel therapeutic targets to mitigate disease progression. We will use a novel in-vivo strategy to understand protein-level changes that specifically occur in neurons in mouse models of Alzheimer’s disease pathology and will define the contribution of the brain’s innate immune cells (microglia) to these early synaptic changes.